MEANINGS OF RACE, CLASS, AND GENDER IN HEART DISEASE

The four broad, long-term objectives of the proposed research include: (a) improving the conceptualization and operationalization of race, class, and gender in epidemiologic and health services research; (b) elucidating the processes through which, and the social contexts within which, racial- ethnic, class, and gender differences are thought to make some individuals more vulnerable to cardiovascular disease (CVD) and its adverse outcomes; and (c) understanding how racial-ethnic, class, and gender backgrounds of individuals influence their conceptions of health risks, behaviors, relationships with health providers, and understandings of chronic illness and disability. The research undertakes an examination of the disciplinary conventions and practices of epidemiology and health services research, and of the experiences of individuals with CVD. The three specific aims of this research are: (1) to illuminate the ways in which race, class, and gender have implicitly or explicitly been conceptualized and studied in epidemiologic and health services research on CVD; (2) to examine how definitions of race, class, and gender conventionally used in such research have shaped what we know about inequalities in CVD incidence and outcomes; and (3) to explore how individuals with CVD themselves view their racial-ethnic, class, and gender backgrounds as having effects on their social and economic circumstances and resources, health beliefs and behaviors, access to and evaluation of medical information, and ultimately on their cardiovascular health. The methods for achieving these aims are: content analysis of published reports; participant observation of presentation and discussion at epidemiologic and health services research conferences; in-depth interviews with 10 medical investigators of CVD; and in-depth interviews with 10 Asians/Pacific Islander, 10 Black, and 10 Hispanic men and women with coronary heart disease or hypertension. Qualitative analysis will be conducted using systematic processes of coding and category construction that enable constant comparison of findings across data sources.